Evaluation of brain recovery of stroke patients using a novel magnetic resonance compatible hand induced robotic device combined with magnetic resonance imaging

The broad, long-term objective of this study is to improve therapy efficacy for, and thus the
quality of life (QoL) of, stroke patients. An increasing number of individuals suffer from
stroke. Disabilities resulting from stroke were considered irreversible until very recently.
Stroke recovery is an emerging field, still overcoming the longstanding view of functions lost to
stroke being non-recoverable.
We hypothesize that (a) robotic devices that stimulate brain recovery via motor
training can support restoration of movement abilities compromised by stroke-induced
pathological changes in the brain; and that (b) post-stroke neural changes can be
monitored (and therefore later predicted) by in vivo state-of-the-art magnetic resonance
imaging (MRI) via brain recovery biomarkers and behavioral motor performance improvements.
To test this hypothesis, we propose to conduct a longitudinal study of our novel hand device in
conjunction with 3-T brain MRI to monitor recovery in patients with chronic stroke via three Aims.
Aim (1) is to perform state-of-the-art MRI with newly-developed phased-array coils and parallel
imaging (to maximize sensitivity and resolution) to document quantifiable brain changes during
training in 100 chronic stroke patients with confirmed middle cerebral artery (MCA)
territory ischemic stroke and ischemic lesions affecting the motor strip. Patients will be assigned
randomly to a training group and non-training control group. Participants will train for 30 min/d,
3 d/wk, to be conducted at home to facilitate participation. Volumetric MRI, functional MRI
(fMRI), and diffusion tensor imaging (DTI) will be performed before the start of
treatment (baseline) and then monthly over a 3-month training period. MRI measurements
will focus on the motor cortex and its surrounding cortical areas and connecting tracts. Aim (2)
is to evaluate motor performance in these chronic stroke patients with standard clinical
indices and hand device measurements. Aim (3) is to demonstrate that brain mapping
based on state-of-the art MRI in conjunction with hand device-assisted therapy can
provide novel biomarkers for chronic stroke recovery while improving clinical outcome. We will
perform a meta-analysis of structural, fMRI, DTI, and motor performance data using a
general linear mixed-model (GLMM) approach, which handles heterogeneous data and
facilitates deduction of useful results despite inter-individual variability.
Impact: Success will facilitate selection of patients and personalized treatment planning
optimized to yield improvements based on MRI metrics. Specifically, this study may
identify biomarkers of brain recovery that can be monitored during therapy, inform therapy
adjustments, and advance our ability to predict stroke recovery outcome. For chronic stroke
patients, we anticipate demonstrating that recovery is possible for a longer period of time than
previously thought, including motor skill improvements beyond 6 mos. after a stroke
event, owing to the capacity for brain plasticity and functionally adaptive
reorganization. If this research indicates continued improvement with physical therapy,
then the limitations of Medicare and other insurances should be extended to assist in longer-term
recovery of stroke victims, thus improving their QoL, especially in the geriatric patient
population, where stroke is most prevalent.

Public health relevance
Stroke is a major cause of morbidity and invalidity in modern society. Our novel Magnetic Resonance Compatible Hand Robotic Device combined with state-of-the-art in vivo magnetic resonance imaging of brain structure and function will provide a biomarker that can be used to evaluate and predict the effects of training on the motor skills and brain recovery of stroke patients. The findings will advance stroke recovery research, which has been hampered from the longstanding view that lost functions were not recoverable and may ultimately contribute to improving the quality of life of stroke patients especially in the elderly where stroke is more prevalent.